Wireless Implantable Mechano-Acoustic Recording Device

PROJECT SUMMARY - ABSTRACT
Following a highly successful Phase I, we will integrate closed-loop optogenetic capabilities into our fully
implantable, wireless, battery-free, Mechano-Acoustic (MA) device. Additional antenna booster coil designs will
increase cage power to the devices and allow larger open-field enclosures to be utilized. The MA device acquires
multi-parameter physiological data from freely moving small animal models, via use of a high bandwidth triaxial
accelerometer and temperature sensor to record vital sign information such as the heart and respiration rate and
body temperature, and other general features about the animal that include locomotion and body orientation.
Each of these features are determined in parallel from subtle motions detected with this platform using the most
advanced inertial measurement unit (IMU) technology and transmitted wirelessly and analyzed in real-time using
Bluetooth Low Energy (BLE) 5.2 to an external reader system – all isolated to individual subjects within
experimental contexts spanning single to multi-animal behaviors. This approach allows other experimental
approaches (video tracking, neural recording, etc.) to be directly coupled to the recorded physiological data. By
delivering both power and data wirelessly, and by entirely eliminating all external fixtures and physical tethers
on the animal, the proposed technology enables chronic physiological recordings in three-dimensional
naturalistic environments, from isolated individuals or social groups, in ways that are fundamentally impossible
with conventional hardware infrastructure. This low-cost manufacturable system is fully compatible with the
NeuroLux radio frequency wireless electronic platform and control software, allowing us to leverage the strengths
of an existing commercial platform currently in use worldwide to further advance behavioral and physiological
research capabilities.

Public health relevance
PROJECT NARRATIVE The proposed program integrates closed-loop optogenetic functionality (hardware and software) into a fully implantable, battery-free device for wireless data acquisition of physiological data including heart and respiratory rate, body temperature, and other behavioral information such as locomotion and orientation of rats and mice. This novel technology, which is fully compatible with the NeuroLux radio frequency wireless electronic platform, represents an important advanced tool for experimental behavior research that enables non-tethered, non- invasive operation in cages with simple or complex environments in individual or groups of animals.